A Comparative Effectiveness Trial of Strategies to Implement Firearm Safety Promotion as a Universal Suicide Prevention Strategy in Pediatric Primary Care

Program Director/Principal Investigator (Last, First, Middle): Beidas, Rinad Sary
The proposed study will work to reduce firearm-related suicide deaths in young people by investigating the
most effective way to implement a universal safe firearm storage program in pediatric primary care. The
number of young people dying by suicide in the United States continues to rise, and risk for suicide death is
much greater when there is an unlocked, loaded firearm in the home. A simulation study found that a modest
increase in safe firearm storage could prevent up to 32% of firearm-related deaths in youth. Pediatric primary
care is an ideal setting for universal suicide prevention strategies to reduce access to firearms, and prior
research has shown that both health care clinicians and parents find firearm safety to be an appropriate topic
to discuss, yet these conversations do not happen routinely. Safety Check, an evidence-based practice for
firearm safety promotion that involves brief counseling and provision of a free cable lock, has been shown to
double the odds of self-reported safe storage among parents but has not been implemented widely. Using
feedback from pediatric clinicians, health system leaders, and firearm-owning parents regarding attitudes and
barriers related to broader use of the program, the proposed study incorporates recommendations on how to
boost the acceptability and feasibility of Safety Check for use as a universal suicide prevention strategy.
Combining this feedback with insights from behavioral economics, we will conduct a hybrid type III
effectiveness-implementation with a longitudinal cluster randomized design. The study will allow us to compare
two approaches to implementing the program in pediatric primary care and evaluate the effectiveness of the
adapted intervention, now named Gun Safe. The study will include 151 clinicians in 32 clinics who serve
38,989 youth annually in two MHRN health systems in Michigan and Colorado. All 32 clinics in the two
participating health systems will receive Gun Safe materials, including brief training and cable locks. Half of the
clinics (k = 16) will be randomized to receive the EHR implementation strategy (Nudge); the other half will be
randomized to receive Nudge plus 1 year of facilitation to target additional clinician and organizational
implementation barriers (Nudge+). We will collect the primary implementation outcome for 6 months before
exposure to condition and for 1 year following to allow for comparisons between (a) the active and pre-
exposure periods and (b) the active and sustainment periods. Results will guide future efforts to promote
firearm safety as a universal suicide prevention strategy. In Aim 1, we will identify the effect of the
implementation strategies on implementation outcomes (i.e., parent-reported clinician fidelity, reach (how many
families received the intervention), cable lock distribution, acceptability, and cost). In Aim 2, we will also test
potential implementation strategy mechanisms (i.e., how it worked). In Aim 3, we will examine clinical
outcomes including a parent-reported safe storage behavior. This study can improve implementation of firearm
safety interventions and identify the best approach to national implementation, with the ultimate goal of saving
the lives of American youth, in alignment with NIMH Objective 4.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Beidas, Rinad Sary PROJECT NARRATIVE Reducing access to firearms is a key strategy for suicide prevention in youth, yet many young people live in homes with firearms that are not safely secured. The proposed work has the potential to radically impact public health by testing which strategies are most effective in helping pediatric primary care clinicians to deliver an evidence-based firearm safety promotion program in pediatric primary care as a universal suicide prevention strategy. This clinical trial will take place in two large health systems in Michigan and Colorado and will use principles from behavioral economics to support clinician behavior change while also gathering information about effectiveness, acceptability, and costs, in order to inform large-scale program implementation efforts within the Mental Health Research Network and nationally to save the lives of American youth. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page